APOBEC Mutagenesis in Cancer

OVERALL – APOBEC MUTAGENESIS IN CANCER
ABSTRACT
APOBEC enzymes are single-stranded DNA cytosine-to-uracil (C-to-U) deaminases. APOBEC mutagenesis
has emerged as the 2nd largest source and the largest actionable source of mutation in cancer. It impacts 70%
of all cancer types and is the dominant mutagen in large numbers of bladder, breast, cervical, head/neck, and
lung tumors. APOBEC mutagenesis is defined by signature base substitution mutations (C-to-T and C-to-G
mutations) in 5′-TCA and 5′-TCT motifs, but its impact is much broader with many C-to-U deamination events
leading to DNA breakage, insertion-deletion mutations, and larger-scale chromosomal aberrations. Importantly,
for many cancer types, increased levels of APOBEC associate with detrimental clinical outcomes including drug
resistance and metastasis. We therefore hypothesize that APOBEC inhibition will decrease mutation rates, slow
tumor evolution, and improve the clinical outcomes of many existing anti-cancer therapies. Three
multidisciplinary Projects work together in an integrated and comprehensive manner to test this unifying idea.
Project 1 is leveraging structural approaches to delineate atomic interactions between APOBEC enzymes and
interacting proteins, nanobodies, nucleic acids (substrates and competitive inhibitors), as well as small
molecules.
Project 2 is providing chemical innovation to the Program by optimizing nucleic acid-, peptidomimetic-, and small
molecule-based APOBEC inhibitors and degraders that will ultimately yield potent, selective, and cell-permeable
molecules, with low cytotoxicity.
Project 3 is investigating protein-level APOBEC regulatory mechanisms, as well as molecular mechanisms
downstream of genomic DNA C-to-U deamination. Cellular and murine systems developed here are also
essential for testing candidate APOBEC inhibitors developed and characterized by the combined activities of the
Program team [Project 2 (chemistry) with essential support from Project 1 (structural biology), Core B (proteins
and assays), Core C (computational optimization), and Core A (administration)].
All Projects are supported by service Cores for administration, proteins and assays, and computational
biochemistry and bioinformatics. This is a competitive renewal of a highly productive Program with over 50
publications in the initial support period. The next phase of studies will have both immediate and long-term
impacts on multiple cancer types: immediate by producing standardized reagents, novel technologies, and a
comprehensive understanding of the molecular mechanism of APOBEC mutagenesis, and long-term through
the development of novel chemical matter matter to suppress this mutational process and help improve the
efficacy of existing cancer therapies.

Public health relevance
OVERALL – APOBEC MUTAGENESIS IN CANCER NARRATIVE Mutations accumulate in cancer cells continuously after the disease is first diagnosed and treated, leading to poor outcomes including treatment resistance, cancer recurrence, and metastasis. APOBEC contributes to this ongoing mutagenesis in many cancers and thus inhibition of APOBEC (especially after tumor cell numbers are reduced by surgery and/or therapy) provides an opportunity to slow or prevent cancer recurrence and progression. Our Program takes a multidisciplinary approach to better understand the molecular mechanism of APOBEC mutagenesis in cancer, with the overarching long-term goal of stopping this mutation process and thereby making current and future treatments more effective.